Network Coordinating Center

PROJECT SUMMARY/ABSTRACT – NETWORK COORDINATING CENTER
The Network Coordinating Center (NCC) will facilitate and be responsible for network-wide coordination and
harmonization of scientific and clinical needs of the funded U19 centers comprising the Glioblastoma
Therapeutics Network (GTN). The NCC will serve as the administrative hub and coordinating center for all
network-related trials and projects. This will include multiple aspects of the functioning of this network,
including but not limited to: (1) administrative coordination of the GTN, (2) coordination and standardization of
biospecimen procurement, biobanking, and transport practices, (4) development of standard operating
procedures for the functioning of the network and data management, (5) support of meetings and
communications among members of the GTN and with the GTN Steering Committee, and (6) creation and
maintenance of a GTN website. An efficient NCC that facilitates easy communication and functioning of the
GTN will be critical for the success of this network. The infrastructure, expertise, and experience of the
individuals at Mayo Clinic with national coordination of translational and clinical neuro-oncology research is
extensive, making this group well-positioned to function as an outstanding NCC for the GTN. The leadership of
this proposed NCC bring with them complementary and deep experience and background across these key
aims and have worked extensively with multi-institutional trials, consortia, and networks as well as cooperative
groups in research leadership, trial coordination and implementation, data structures, and importantly
development of SOPs and guidance for newly formed collaborative research networks across multiple
institutions. Beyond the experience and expertise, the Mayo Clinic NCC also leverages institutional
infrastructure and resources to adapt and evolve as the GTN develops and grows through the expected and
necessary collaborations across all U19 centers and project leaders.